Development of Computer Aided Design of Helical Arylamide Foldamer Receptors for Selective Carbohydrate Recognition

ABSTRACT Carbohydrates are ubiquitous and critical in many biochemical and disease pathways. They regulate many pathological processes, such as cancer metastasis, microbial and viral infections, and inflammation, and are biomarkers for pathogens (e.g. HIV), and a range of cancers (e.g. breast, ovarian, prostate, lung and colon). Therefore, carbohydrates hold a great promise for health-related diagnostic, detection, therapeutic and research applications. Yet, they are among the most difficult targets for molecular recognition, due to their immense variety, and subtle, but consequential structural differences. These include anomers, ring-closure isomers, many stereocenters, branching points, and chemical modifications, resulting in remarkably high similarities between species. Thus, a major obstacle for further development of effective receptors is selectivity. Despite an intense experimental effort, designing sugar receptors with high affinity and selectivity still poses a serious challenge. We propose to develop an approach for computationally aided design of foldamer receptors with high selectivity, based on specifically tailored non-covalent interactions and tight shape fit. The approach combines rational, combinatorial and iterative optimization design components. It is to be general, applicable to a variety of carbohydrate targets. Furthermore, it will rapidly generate optimal lead sequences for synthesis, and thus result in a transformative increase in efficiency and speed of producing carbohydrate receptors. The goal of the proposal is to establish a computer-aided strategy for designing receptors that selectively recognize carbohydrate targets based on the position and orientation of sugar's OH groups, their hydrophobic patches, and molecular shapes. Chemical entities particularly amenable for such a receptor design are foldamers, oligomers that fold into stable secondary structures. Their attractiveness for the proposed combined rational and combinatorial design stems from their modularity, stability, general structure predictability and ease of synthesis. We focus on arylamide foldamer based receptors as they have been recently shown to have unprecedented selectivity towards tested sugars. In the past several years, we have been developing computational approaches for predicting foldamer structure, dynamics and ligand binding modes, and are thus in a unique position to advance the proposed idea using arylamide foldamers as the chemical basis for receptor design. An additional value of the proposed work is that it will be adaptable to other modular supramolecular scaffolds and targets.

Public health relevance
NARRATIVE Highly selective carbohydrate receptors are needed as diagnostic and therapeutic agents, because carbohydrates play critical roles in biochemical and pathological pathways. For example, they are biomarkers for pathogens and a range of cancers. Despite the great need, the development of synthetic carbohydrate receptors has however been slower than desired. We propose to develop a computer aided design of carbohydrate receptors which will result in a transformative increase in efficiency and speed of producing effective carbohydrate receptors.